XXIII Ovarian Workshop

Abstract
Central to the mission of the Fertility and Infertility Branch of NICHD is advancing women's reproductive health
through support for basic and translational research. The XXIII Ovarian Workshop serves as a dynamic platform
for fostering collaboration and sharing research progress among basic science researchers, clinicians, and
trainees in the field of ovarian biology and pathobiology. This R13 sponsors an international symposium as a
preconference workshop to the Society for the Study of Reproduction's (SSR) Annual Meeting, and features
eleven distinguished speakers from five countries. The workshop focuses on cutting-edge ovarian biology
research, emphasizing emerging technologies to explore communication between key ovary cell types
necessary for female fertility. The program topics include updates on the NICHD-funded Human BioMolecular
Atlas Program (HuBMAP), bioengineering for ovarian follicle signaling, novel methods for species conservation,
improvements in imaging technologies, and new facets to ovarian aging. The Ovarian Workshop promotes
diversity and inclusion by inviting active participation from diverse individuals. Previous Ovarian Workshops have
hosted speakers and attendees with diverse perspectives across geography, gender, race, ethnicity and career
stages. Our slate of confirmed speakers continues with this legacy and encourages interdisciplinary
collaboration. The Ovarian Workshop aims to (1) provide a forum for sharing recent breakthroughs in ovarian
biology focusing on advancements in cell-cell communication and innovative technologies, (2) facilitate scientific
interaction and collaboration among colleagues and trainees, promoting professional development at all levels,
to meet the increasing need for research in ovarian biology and health for individuals with ovaries, and (3) offer
a forum for trainee and junior investigator engagement and promote inclusivity in ovarian research by
encouraging participation by individuals typically underrepresented in science as a mechanism to further their
professional development. These goals will be met through interactive sessions, panel discussions, and
networking opportunities. Trainees will showcase their research in a dedicated Rising Star session, fostering
valuable networking and mentoring. Highlights from this Ovarian Workshop will be published in the SSR journal,
Biology of Reproduction, co-authored by the organizers. By uniting experts and prioritizing trainee involvement,
the Ovarian Workshop will cultivate a vibrant, inclusive community dedicated to advancing ovarian research as
a foundation to female reproduction and overall health. The conference is anticipated to influence research
directions, foster new and strengthen prior collaborations, and contribute to mentorship for the next generation
of ovarian biology researchers and thought leaders.

Public health relevance
Project Narrative This R13 application seeks funding for the XXIII Ovarian Workshop, scheduled for July 15-16, 2024 at the Convention Center Dublin, Ireland, as a preconference workshop prior to the Society for the Study of Reproduction Annual Meeting. The workshop will unite leading scientists and trainees from around the world to exchange ideas, present new research, and provide mentorship in a supportive and inclusive environment that collectively addresses key challenges and supports future discoveries in ovarian biology and women's health.